The Extracellular Matrix as a Determinant of Filovirus Infectivity.

Filoviruses (Ebola [EBOV] and Marburg [MARV]) are emerging global pathogens that cause both acute
hemorrhagic disease and chronic persistent infections with long-term sequelae and death. A comprehensive
understanding of the filovirus-host interactome is critical for the development of novel host-oriented
countermeasures to treat or prevent these deadly viral infections. We have recently identified YAP (Yes-
Associated Protein; the downstream transcriptional effector of the Hippo pathway), and filamin A and B, members
of a family of actin crosslinking/stabilizing proteins, as novel host determinants of viral infectivity, egress, and
spread. Functionally, we find that filamin-A is critical for mediating infectivity of authentic EBOV and MARV in
multiple cell types including primary human macrophages, while in contrast, filamin-B restricts filovirus infectivity.
Filamin-A forms a mechanosensory complex with β1 integrin to transduce signals from the extracellular matrix
(ECM) to internal signaling pathways such as the Hippo pathway, a critical regulator of proliferation, migration,
and EMT (epithelial mesenchymal transition) induction. Previously, we found that filamin-A-deficient melanoma
cells are softer than wild-type cells and maintain the Hippo pathway in an ON condition in which YAP is
predominantly cytoplasmic. Together with our recent data, these findings support the novel hypothesis that ECM
composition and stiffness will impact EBOV/MARV infectivity, with EBOV/MARV more easily infecting cells
embedded in a stiffer ECM (where YAP is transcriptionally active) than in a softer ECM (where YAP is
transcriptionally inactive). In Aim 1, we will test our hypothesis that ECM stiffness is a determinant of filovirus
infectivity using innovative approaches, such as atomic force microscopy (AFM), viscoelastic polyacrylamide
(PAA) hydrogels, and live filovirus infection assays. In preliminary studies to identify host proteins that
functionally contribute to the robust and opposing effects of filamin-A and filamin-B on EBOV/MARV infectivity,
we identified 5 ECM-associated proteins, a subset of which are YAP target genes. In Aim 2, we will use
innovative approaches including live filovirus infection, pseudotype transductions, CRISPR/Cas9 KO cells, and
RNA Seq. to determine whether expression of these 5 candidate ECM-associated proteins modulate filovirus
infectivity. Intriguingly, EBOV infection induces EMT, and we have recently identified YAP as a novel
EBOV/MARV VP40 interactor and regulator of filovirus egress and spread. Based on these data, in Aim 2 we
will also test the novel hypothesis that filovirus infection will reciprocally impact the cellular environment by
affecting YAP localization/transcriptional-activity and expression of ECM-associated proteins within the
matrisome. Findings from this exploratory proposal will provide a solid foundation for future studies designed to
interrogate more mechanistically the role of the ECM and matrisome in regulating filovirus infection, the
subsequent host immune response, and the potential to manipulate the ECM to inhibit filovirus infection.

Public health relevance
We have recently identified host proteins associated with the extracellular matrix (ECM) as novel determinants of filovirus infectivity, egress, and spread. Here, we will determine whether the composition and stiffness of the ECM impact filovirus infectivity, and whether filovirus infection will reciprocally impact the cellular environment by affecting expression of ECM-associated proteins. Findings from this exploratory proposal will provide a foundation for future interrogation of the role of the ECM in regulating filovirus infection, the subsequent host immune response, and the potential to manipulate the ECM to inhibit filovirus infection.